Reducing Dynamic Hyperinflation through Breathing Retraining

DESCRIPTION (provided by applicant): Abstract Dynamic hyperinflation limits exercise duration in chronic obstructive pulmonary disease (COPD). To limit dynamic hyperinflation during exercise and thus improve exercise duration, we successfully developed a visual-auditory ventilation-feedback system. The system retrains patient's breathing pattern during exercise. The goal of the current proposal is to develop a user-friendly ventilation-feedback technique with a novel auditory feedback system. We reason that the proposed feedback system plus exercise training will be superior to exercise training alone while having the potential for an easier application into clinical practice. Hypotheses: The primary hypothesis is that the exercise duration of patients with moderate-to-severe COPD who successfully complete a 12-week program of breathing retraining plus exercise will be longer than that of patients who complete a 12-week program of treadmill exercise training alone. We also hypothesize that the primary predictor of improved exercise duration will be a reduction in dynamic hyperinflation and to a lesser extent, improvement in peripheral muscle function. Lastly, we hypothesize that dyspnea will be reduced in patients assigned to breathing retraining plus exercise when compared to exercise training alone. Methods: The proposed study is a randomized controlled clinical trial. 246 patients with moderate-to-severe COPD will be enrolled and randomized into breathing retraining plus exercise or exercise training alone. Both groups will receive 12-weeks of treadmill exercise training three times weekly. The breathing retraining plus exercise group will also receive auditory feedback to decrease respiratory rate and prolong exhalation. The goal of breathing retraining is to reduce exercise- induced dynamic hyperinflation. Follow-up testing will be completed at 6, 12, and 24 weeks. Testing will include a pulmonary function test, symptom-limited and constant workrate treadmill tests, six-minute walk, dyspnea measurements, testing of respiratory muscle strength and endurance, and quadriceps muscle endurance testing. Analysis: Measures of central tendency will be used to describe the study sample. A two-sample t-test (1 = 0.05) will be used to analyze changes from baseline to 12-weeks between the breathing retraining plus exercise group and exercise training alone group. In data analysis, intention-to-treat principles will be used. Since several measures will be taken on each patient, mixed-models analysis will be used to compare changes over time between the two groups. Multiple regression analysis will be employed to determine the predictors of improved exercise performance. PUBLIC HEALTH RELEVANCE: Relevance_Narrative Relevance to the VA. COPD is the fourth leading cause of death in the United States and the sixth most common chronic condition cited among veterans enrolled in the Veterans Health Administration. Over 16 million individuals in the United States are afflicted with COPD. As compared with the general population, patients with COPD are more likely to rate their health as poor, to report more limitations in daily activities, to visit their physician, to stay in the hospital and to report more disability days. More than 17 million office-visits and over 700,000 hospitalizations resulted from COPD. Innovative approaches to pulmonary rehabilitation of patients with COPD may be instrumental in modifying this cyclical pattern of increasing impairment leading to more hospitalizations and decreasing reserve to cope with the stress and strain of daily living.

Public health relevance
Relevance_Narrative Relevance to the VA. COPD is the fourth leading cause of death in the United States and the sixth most common chronic condition cited among veterans enrolled in the Veterans Health Administration. Over 16 million individuals in the United States are afflicted with COPD. As compared with the general population, patients with COPD are more likely to rate their health as poor, to report more limitations in daily activities, to visit their physician, to stay in the hospital and to report more disability days. More than 17 million office-visits and over 700,000 hospitalizations resulted from COPD. Innovative approaches to pulmonary rehabilitation of patients with COPD may be instrumental in modifying this cyclical pattern of increasing impairment leading to more hospitalizations and decreasing reserve to cope with the stress and strain of daily living.